Clinical Services Research Training Program

ABSTRACT
Among NIMH's top priorities is the continued support of clinical services, interventions, and policy research
focused on bridging the dissemination and implementation gap between science and service. For the past 35
years, our training program, called the Clinical Services Research Training Program (CSRTP), has launched
the careers of clinical services investigators, many of whom are now leaders in the field, by providing high
quality education and support to postdoctoral scholars from a variety of disciplines (including psychology,
social work, epidemiology, sociology, medicine, health economics, and nursing) who plan to pursue careers in
mental health services research. The graduates of the CSRTP have been extremely successful: eighty-five
percent (85%) obtained academic or research positions; of those, 77% received research support from
extramural, primarily federal, research funds. Over half (63%) of the graduates are women and a third are
racial/ethnic minorities. During the last ten years, 26% of the fellows appointed classify themselves as
members of under-represented minorities. Of the women who have graduated from CSRTP, 73% received
extramural funding for their research; 88% of the racial/ethnic minority graduates obtained extramural research
grant support. CSRTP graduates contributed substantively to the extant literature, producing over 550 peer-
reviewed publications to date. Given the success of our program, we seek five additional years to continue
providing high quality training to four postdoctoral fellows a year (duration of program tenure is planned for two
years each) who promise to be outstanding leaders in the next generation of clinical services researchers. Our
training goals are (1) to help postdoctoral fellows acquire sufficient methodological knowledge and research
skills to conduct high quality clinical services and interventions research; (2) through study and experiential
learning, to help postdoctoral fellows acquire knowledge about the most important pressing and contemporary
issues in clinical services research; (3) to assist postdoctoral fellows to attain professional skills essential to
career advancement in academic and research settings; and (4) to help postdoctoral fellows develop a national
scientific peer network within specific research areas.

Public health relevance
Project Narrative The NIMH identifies an urgent unmet need for science focused on improvement and development of interventions for individuals suffering from mental illness that are acceptable and easily disseminated to the service community and supported by policy makers. The UCSF Clinical Services Research Training Program trains junior investigators in the practices of clinical services research, relevant research methods, and professional skills. The program's success is reflected in the success of its graduates who have continued in clinical services research careers, many being leaders in the field, through academic/research positions, funded research programs and active dissemination of their research.